Mechanisms of microglial-mediated sex-based differences in tauopathy

PROJECT SUMMARY/ABSTRACT
Microglia, the resident innate immune cells in the brain, are increasingly recognized as key players in the
pathogenesis of tauopathies like Alzheimer’s disease (AD) and related dementias (ADRDs). Across humans and
mouse models of ADRDs, sex-based differences exist in the prevalence and pathophysiology of disease, but
the mechanisms by which sex-based biology contributes to neurodegeneration are understudied. Microglia are
known to exhibit sex-based differences across a variety of diseases. The Condello Lab found that upon microglial
depletion, female mice exhibit a sex-specific functional rescue and extended survival in a mouse model of
tauopathy (Tg2541), thus microglia mediate some sex-based differences in tauopathy. Interestingly,
inflammatory phenotypes in microglia can be modulated by estrogens and recent studies have shown that age
of onset of menopause can affect levels of tau burden, thus levels of gonadal hormones may contribute to tau
deposition. With age as a significant risk factor for the pathogenesis of tauopathies and the changes in gonadal
hormones over the course of aging (e.g., menopause and andropause), we hypothesize that gonadal hormones
contribute to sex-based differences in tauopathy through their activity on microglia. The objectives of this
proposal are to determine the effects of gonadal hormones on (1) sex-based transcriptomic and morphologic
signatures of microglia and (2) sex-based differences in disease phenotypes of tauopathy. Using the Tg2541
transgenic mouse model of tauopathy and wildtype controls, mice will undergo gonadectomies to deplete the
endogenous sources of estradiol, progesterone, and testosterone; sham surgeries will be performed as control.
In Aim 1, the effects of gonadal hormones on microglial cell states will be explored using a combination of single-
cell RNA sequencing to assess transcriptionally distinct subtypes of microglia and spatial transcriptomics to
assess microglial phenotypes across brain regions and in relation to tau deposition. Other microglial features
that exhibit sex-based differences, such as morphology, will be assessed via immunofluorescent staining. In Aim
2, time course and longitudinal studies will be performed to assess the impact of gonadal hormones on the
progression of disease pathology, behavior, and survival in the Tg2541 model. Completion of this proposal will
shed light on how sex-based biology contributes to the microglial-mediated sex-based differences in tauopathy
and provide a rich transcriptomic dataset that can be leveraged for further mechanistic studies. An increased
understanding of the impact of gonadal hormones on microglia and tauopathy will be critically important for the
design of microglia-specific therapeutics for ADRDs that can be effective in males and females. The UCSF
Institute for Neurodegenerative Diseases (IND) provides an ideal environment for the completion of the proposed
work, offering rigorous training in animal models, bioinformatics, and confocal microscopy, as well as support for
professional development. Furthermore, the sponsors are committed to the comprehensive training plan we have
developed that will prepare me for my career as a scientific leader in biomedical research.

Public health relevance
PROJECT NARRATIVE Microglia are increasingly recognized as key players in neurodegeneration, including tauopathies like Alzheimer’s disease (AD) and related dementias (ADRDs), which are diseases that display sex-based differences in both humans and mouse models of disease. While microglia are recognized to contribute to sex- based differences in tauopathy, the mechanisms of sex-based biology affecting both microglia and disease have not yet been explored. This proposal aims to understand the impacts of gonadal hormones on sex-based differences of microglia and tau pathology, which is crucial for the implementation of microglia-specific therapeutics for ADRDs that can be effective in males and females.